Host-Directed Therapy to Augment anti-M. tuberculosis Responses in the Setting of HIV Co-infection and to Sterilize the Tuberculoma

Abstract
Mycobacterium tuberculosis (Mtb) infection can lead to tuberculosis (TB) disease, causing ~9 million new
infections and ~1.8 million deaths globally, every year. A quarter of these are deaths due to the TB/AIDS
comorbidity, caused by Mtb/HIV co-infection and the resulting reactivation of LTBI. The resurgence of TB in the
last two decades can be attributed to the failure of the anti-TB vaccine, Bacille Calmette-Guerin (BCG) in
containing adult, pulmonary TB as well, the emergence of drug-resistance and the AIDS pandemic. The failure
to control TB stems from the lack of complete understanding of the virulence and pathogenesis programs
utilized by this highly specialized and successful pathogen in order to persist in the lungs of its hosts. As part of
its virulence cycle, Mtb modulates host immunity.
We have developed a robust macaque model Mtb/HIV co-infection, by using natural routes of Mtb infection
and by using Simian Immunodeficiency Virus (SIV) as a surrogate for HIV. This model can be leveraged to
study the physiology of Mtb in a true in-vivo setting. Using our model, we show that the expression of IDO
(INDO, IDO1), a powerful immunosuppressant of activated CD4+ T cells, is dramatically enhanced in the lung
granulomata of macaques. Levels of IDO are induced in a bacterial burden specific manner in myeloid cells.
Thus, macaques that control inhaled Mtb infection as LTBI, do not express high levels of IDO in lung lesions,
but those that progress to ATB do. IDO levels decline when animals with ATB are chemotherapeutically
treated. Upon co-infection with SIV, 2/3rds of the macaques with LTBI reactivate disease - only these animals
exhibited lung IDO induction. Finally, nonpathogenic infection with avirulent mutants of Mtb failed to elicit the
induction of IDO. Amelioration of IDO enzymatic activity by an FDA, approved, safe compound in-vivo resulted
in significant reduction in clinical signs of TB, pathology and bacterial burden, and increased survival. This was
accompanied by increased lung T cell proliferation and induction of bronchus associated lymphoid tissue
(iBALT). These events reshaped the granuloma is two different ways: i) functionally granulomas from treated
(IDO blockaded) animals exhibited no signatures of T cell exhaustion but instead higher expression of T cell
differentiation, apoptosis, bacterial killing and lung tissue remodeling pathways; ii) morphologically, greater
relocation of T cells was observed to the center of the granulomata. The profoundly better killing of Mtb in
macrophages by CD4+ T cells could be modeled in-vitro, in a novel macaque macrophage:CD4+ T cell co-
culture system. Our results strongly suggest that IDO modulates a complex immune/metabolic signaling
network that promotes bacterial survival, immune dysfunction and disease. Thus, inhibition of IDO is a prime
target for adjunctive HDT against the multidrug resistant TB epidemic.
Based on these data, we postulate that IDO1-signaling is key to modulating immune responses in human-like
lung granulomas. We now propose to leverage the macaque model of LTBI to study if IDO-blockade in-vivo
can enhance granuloma performance and sterilize Mtb infection. SIV co-infection will be used to test this.
Finally, we will treat Mtb/SIV co-infected animals with a gut homing T cell blocking a4b7 antibody in addition to
blockading IDO. We postulate that this dual treatment will reduce the viral load thus preventing reactivation,
and enhance the sterilizing potential of IDO blockade.

Public health relevance
Narrative The expression of INDO (IDO1), a powerful immunosuppressant of activated CD4+ T cells is dramatically enhanced in classical TB lung granuloma lesions from mice, nonhuman primates and humans as well as during Mtb/SIV co- ‐‑infection. We hypothesize that IDO1 is responsible for modulating the function of activated CD4+ T cells with TB granulomas and will test if blockading it can sterilize Mtb infection; and if blockading IDO along with a proven functional cure for SIV will reduce the rate of reactivation.